Outreach, Recruitment and Engagement Core

Mount Sinai ADRC (Sano): Outreach, Recruitment and Engagement Core (Core E) – Research
Summary
The overarching goals of the Outreach, Recruitment and Engagement Core are to provide targeted outreach to
a culturally, racially and cognitively diverse group of elders to insure recruitment and retention for investigators
in the ISMMS-ADRC and allied collaborators. Our activities are well-integrated with the other Cores and our
accomplishments have been achieved through close collaboration with other departments at the Mount Sinai
Health System (MSHS), and a number of community organizations including the CaringKind (formerly the
Alzheimer's Association), Project Linkage, and Union Settlement. New collaborations with other MSHS including
the Center for Spirituality and Health that will enable the Core to expand our extensive outreach into new
communities throughout the Metropolitan area. The Core will disseminate information widely and explain new
knowledge to professionals, trainees and the lay public. This will be accomplished by providing stimulating
outreach programs in English and Spanish that include the presence of our Community Advisory Board, Memory
Enhancement Program seminars, new written and web-based information, and community events that publicize
the latest developments in dementia research such as the importance of prevention and biomarker studies. Our
outreach efforts will expand to more cognitively health or mildly impaired elders through our culturally diverse
Recruitment Registry. The Core will accomplish targeted recruitment in part by creating an Accelerator
comprised of researchers, community stakeholders, clinicians, caregivers and diverse community elders to
identify research priorities, address barriers to research participation and guide the development of recruitment
strategies and tools to serve the Clinical Core and other allied researchers. Retention and engagement will be
fostered through expanding our successful programs (e.g. Participant Appreciation day, and the Newsletter) as
well through as a new program featuring a social worker. This new retention program, which is currently funded
by philanthropy, addresses caregiver needs as well as exploring potential barriers to research participation.
Needs analyses and assessment of the return on our recruitment and outreach investments and surveys and
interviews will help modify programs and guide future projects. Outcomes will be evaluated through feedback
forms, surveys, questionnaires, and pre-post tests and results will be used to modify and plan future efforts.